Dissecting Neural Mechanisms Supporting Mind and Body Approaches to Pain Reduction in Youth with Migraine

Migraine affects over 6 million children and adolescents in the U.S. and leads to significant pain and disability.
Cognitive behavioral therapy (CBT) effectively reduces the number of headache days in pediatric patients.
CBT includes distinct components, including mind and body approaches (deep breathing, progressive muscle
relaxation, imagery, biofeedback) and cognitive reappraisal training (CR). While the new strategic plan of the
National Center for Complementary and Integrated Health highlights “Neurobiological Effects and
Mechanisms” as a top scientific priority for non-pharmacological pain research, the brain mechanisms by which
components of CBT work remain poorly delineated. To dissect the neural mechanisms engaged by CBT, we
will conduct a mechanistic clinical trial to compare a sample of 80 youth (ages 10 to 17) with migraine who
receive relaxation training (BART) to 80 who receive CR training. Functional MRI and quantitative sensory
testing (QST) data will be obtained before and after intervention (an 8 week period) to address these aims: Aim
1A. Do BART and CR training differentially alter resting brain activation in a fashion related to headache
reduction? Our pilot data indicate migraine patients have pro-nociceptive patterns of functional connectivity
with the amygdala while CBT produces anti-nociceptive patterns of amygdalar functional connectivity. We
hypothesize that BART will preferentially activate the ventromedial prefrontal cortex (vmPFC) while CR training
will preferentially activate the dorsolateral prefrontal cortex (dlPFC) and other regions of cognitive control. To
test this, arterial spin labeling (ASL) MRI will be used to compare pre vs. post training differences in steady
state brain activation in BART and CR groups. Resting state BOLD fMRI will be used to determine if BART and
CR training produce differential alterations of the functional connectivity of the vmPFC and dlPFC with the
amygdala. Aim 1B. Does active performance of BART and CR differentially recruit activation of the vmPFC and
dlPFC? Preliminary data from CBT were obtained during rest and may reflect tonically active consequences of
therapy/headache reduction rather than the phasic mechanisms involved during active engagement of
BART/CR strategies. To further determine if BART and CR involve distinct brain mechanisms, both ASL and
BOLD MRI will be used to compare brain activation and amygdalar functional connectivity during active
performance of each treatment vs. rest. Aim 2. Does the efficiency of pain modulation predict headache
reduction following BART vs. CR? QST assessment of the efficiency of conditioned pain modulation (CPM)
provides an index of the involvement of endogenous pain modulatory mechanisms in both pain conditions and
pain treatments. Our preliminary work has shown that low efficiency of CPM is predictive of headache
reduction following CBT. However, it remains unknown if BART vs. CR is more effective in the presence of
disrupted endogenous pain modulation. Thus, pre-treatment CPM will be used to test the hypothesis that low
efficiency of CPM will be differentially predictive of headache reductions following BART vs. CR.

Public health relevance
Pediatric migraine is a prevalent disorder that results in significant pain and disability for children and adolescents. We need to know about the distinct brain changes that occur in youth with migraine when they receive non-pharmacological treatments, which we know decrease headache days for these patients. This study will lead to greater understanding of the brain and somatosensory mechanisms supporting mind and body approaches (such as biofeedback-assisted relaxation training) to pain reduction in youth ages 10 to 17 with migraine.